ShEEP request for Real-Time Quantitative PCR machine

We are requesting funding for a Real-Time PCR System, the QuantStudio 7 Flex System from Life Technologies Corporation. Work that will be supported includes studies by several groups conducting work towards the understanding and treatment of diseases and conditions of high importance in veteran populations, including traumatic brain injury, alcohol-use disorder, heart failure, atherosclerosis, head/neck cancers and others.

Public health relevance
The equipment requested will be integral to ongoing and planned studies of numerous groups conducting work towards the understanding and treatment of diseases and conditions of high importance in veteran populations, including traumatic brain injury, alcohol-use disorder, heart failure, atherosclerosis, head/neck cancers and others. Thus, these studies are well in line with and supportive of the long-term VAMC goal of improving Veteran's health though targeted and translational research.